Role of cholinergic innervation of the liver

Studies in this proposal will define the role of this cholinergic innervation of the liver in
controlling glucose and lipid metabolism. The dorsal motor nucleus of the vagus (DMV) contains
parasympathetic cholinergic neurons. Although there is a contradictory finding of the lack of
cholinergic innervation to the mouse liver, prior studies with the retrograde neuronal tracers
such as cholera toxin B, pseudorabies virus, and AAV encoding a Cre-inducible reporter protein
strongly support that the mouse liver receives DMV cholinergic innervation. Furthermore, we
have recently published peer reviewed work demonstrating that hepatocytes receive direct
DMV cholinergic input and express muscarinic acetylcholine receptors, suggesting that the
hepatic cholinergic system is critical for proper liver function.
In our recent studies, optogenetic excitation of cholinergic fibers innervating the liver
reduces blood glucose, consistent with the ability of parasympathetic efferent outflow to the
liver to suppress hepatic glucose output. Conversely, optogenetic silencing of liver-projecting
cholinergic nerves elevates blood glucose levels and also stimulates the expression of key
hepatic gluconeogenic genes. As there is no change in plasma glucagon that drives hepatic
glucose production, this effect appears to be pancreatic hormone-independent. In contrast to
the traditional view that the activation of sympathetic nerves promotes, while the
parasympathetic innervation suppresses, hepatic glucose output, our recently published work
strongly supports the significant contribution of DMV cholinergic neurons to hepatic glucose
output in lean mice. Importantly, our pilot studies reveal that ablation of liver-projecting
cholinergic neurons increases hepatic lipolysis and insulin sensitivity in mice fed a high-fat
diet. As hepatic gluconeogenesis and intrahepatic lipolysis are closely linked to each other,
studies in Aim 1 will identify the necessity of these neurons in the control of ingestive
behaviors and hepatic energy metabolism in lean and diet-induced obese mice.
Despite the importance of parasympathetic cholinergic neurons to the regulation of
hepatic glucose output via both insulin-dependent and -independent ways, it is not known that
glucose sensing is an important physiological trigger for this DMV- liver neural circuit. To
address this major gap, studies in Aim 2 will determine if glucose-sensing by DMV liver-
projecting cholinergic neurons controls cholinergic tone to the liver.
While high-fat feeding elevates hepatic sympathetic nerve activity, diet-induced obesity
(DIO) reduces action potential firing of parasympathetic motor neurons. Thus, we have begun
to probe if the hepatic cholinergic system is subject to modulation by the nutrient status. Our
pilot studies reveal that high-fat feeding upregulates Gi-coupled muscarinic acetylcholine
receptor type 2 (M2R) and 4 (M4R) expression in the liver. Accordingly, studies in Aim 3 will
test the hypothesis that diet-induced alterations in the hepatic cholinergic system disrupt whole-
body energy homeostasis and hepatic energy metabolism, causing insulin resistance and
hepatic steatosis in DIO.

Public health relevance
Narrative: Understanding the autonomic regulation of the liver and manipulating the brain-liver circuit have the potential to improve hepatic glucose and lipid metabolism in patients with diabetes. The potential to target specific populations of neurons to restore metabolic homeostasis will provide novel therapeutic targets for the treatment of type 1 and type 2 diabetes.